Integrative Multi-Omics of Metabolomics and Epigenetics to Explore thePathophysiology of Cachexia and Survival in Head and Neck SquamousCell Carcinoma

Cachexia is a common and lethal syndrome affecting up to 80% of patients with advanced cancer, responsible
for approximately 30% of all cancer-related deaths. Despite being a significant factor that worsens patient
outcomes, cachexia remains one of the most under-recognized and undertreated complications in cancer care.
It results in severe muscle wasting, weight loss, inflammation, and profound fatigue, significantly reducing
patients' quality of life and response to treatment. In head and neck squamous cell carcinoma (HNSCC),
cachexia affects 40-50% of patients, leading to a median survival of just 13 months, which is only one-fifth of
the survival time seen in non-cachexic patients. Cachexia remains poorly understood, and there is currently no
approved treatment that effectively reverses this condition. Current management strategies, such as nutritional
support and exercise, are largely ineffective and hope only to halt the condition, not reverse it. The effects of
patient outcomes and lack of treatment options highlight the urgent need for a deeper understanding of the
early biological mechanisms of cachexia to identify opportunities for timely intervention. Recent preclinical
studies indicate that cachexia is driven by early systemic dysfunctions involving tightly interconnected
metabolic, immune, and inflammatory pathways. These complex interactions create a vicious cycle that
accelerates disease progression, highlighting the need for a comprehensive approach to understanding the
systemic nature of cachexia. To address the shortcomings of prior human cachexia research, which focused
mainly on isolated pathways, we propose an integrated multiomics approach to comprehensively explore these
systemic mechanisms in HNSCC patients. By investigating plasma metabolomics, DNA methylation of
circulating white blood cells, and inflammatory cytokines, we aim to identify key biomarkers and mechanisms
driving weight loss, cachexia progression, and survival. Leveraging an existing cohort of over 200 HNSCC
patients with comprehensive pretreatment and longitudinal data, we propose four specific aims: Aim 1 will
compare correlations between immunometabolic markers in cachexic and non-cachexic patients; Aim 2 will
assess associations between plasma metabolomics, DNA methylation, and weight loss; Aim 3 will develop an
integrated immunometabolic network map linking biomarkers to cachexia symptoms; and Aim 4 will evaluate
associations between biomarkers and survival outcomes. This research is highly feasible due to the availability
of an established cohort with extensive pretreatment omics data and longitudinal patient outcomes. By
uncovering the key mechanisms underlying cachexia and their systemic interplay, this study will provide crucial
insights that are currently missing in human cachexia research. The findings could lead to targeted biomarkers
and interventions, ultimately improving early detection, treatment, and quality of life for cancer patients. The
significance of this research lies in its potential to revolutionize our understanding of cachexia as a systemic
disorder and to provide a path toward effective interventions for this devastating condition.

Public health relevance
PROJECT NARRATIVE This research project aims to better understand why some patients with head and neck cancer lose significant weight and muscle during their illness, a condition known as cachexia. We will use advanced tests to study blood samples and identify changes in metabolism, immune response, and inflammation that contribute to this debilitating condition. By understanding these changes, we hope to find new ways to prevent or treat cachexia, ultimately improving quality of life and survival for patients.